In vivo precision genome editing to correct genetic disease

PROJECT SUMMARY
Genetic diseases impact over 1 in 50 newborns worldwide and yet there are no approved therapies
capable of correcting the underlying genetic defects. As a result, most patients continue to suffer throughout
their life and require frequent interventions to ameliorate symptoms. I aim to develop in vivo genome editing
therapeutics that correct the underlying disease mutation in relevant tissues by a single injection into the
patient. Base editors can efficiently correct transition point mutations, the most common form of disease-
causing genetic mutation, without undesired editing outcomes such as indels. With one dose and no
subsequent enrichment, over 95% of cells in tissue culture can be edited, and editing in over 60% of non-
dividing cells in targeted adult mammalian tissues has been demonstrated in early in vivo work. Prime editors
can correct any genetic perturbation of up to at least ~50 nt in length (encompassing ~89% of human disease
mutations). I will develop and assess both precision genome editing technologies (base and prime editors)
using suitable in vivo delivery tools in mouse models to develop therapeutics for genetic disease.
Dilated cardiomyopathy (DCM) is a frequent form of genetic heart disease, affecting an estimated
300,000 people in the United States, and can lead to heart failure. Common causes of DCM are
haploinsufficiency of important genes in cardiomyocytes including TTN and LMNA. I will employ screens to
identify new editing strategies to treat haploinsufficiencies by enhancing transcription of the healthy allele. I will
characterize the mechanism of identified edits to understand the associated changes in transcription factor
occupancy and chromatin states. Simultaneously, I will use fluorescent reporter mice to characterize the in vivo
delivery of base editor and prime editor tools in order to find the best method for editing cardiomyocytes. This
work will include characterizations of tissue- and cell-specific editing following delivery via adeno-associated
virus, lipid nanoparticles, or polymer nanoparticles. I will then combine the identified therapeutic editing
strategy with the best vehicle for delivery to cardiomyocytes to treat a mouse model of TTN haploinsufficiency.
I will measure on- and off-target editing as well as any improvement in the contractility defect that defines this
model. Base editors and prime editors can be readily reprogrammed to correct one or even multiple
simultaneous mutations by altering the co-delivered guide RNA. Future work will expand this screening
methodology to additional haploinsufficiency disorders, and applying identified delivery methods to new models
of genetic disease. The ultimate goal of this work is to develop in vivo genome editing therapeutics that can be
readily adapted to treat even rare or one-of-a-kind disease variants.

Public health relevance
PROJECT NARRATIVE I aim to develop in vivo genome editing therapeutics to treat dilated cardiomyopathy. I will develop genome editor screens to correct TTN haploinsufficiency and as well as characterize viral and nanoparticle delivery methods for base editors and prime editors in vivo in the mouse. I will combine the best identified tools to treat a mouse model of TTN haploinsufficiency, with the ultimate goal of enabling one-time injectable doses to treat dilated cardiomyopathy and other haploinsufficiency disorders.